Sleep-SMART for Veterans with MCI and Insomnia: A Pilot Study

Background: Mild cognitive impairment (MCI) is an important public health concern for aging Veterans due to
the increased risk for progression to dementia and increased mortality. Insomnia is common in MCI (occurring
in up to 60% of patients) and increases risk for dementia, disability, and poor quality of life. Rates of MCI and
insomnia are higher among Veterans than civilians, thus aging Veterans with MCI and comorbid insomnia
represent a particularly high-risk population. The gold standard treatment for insomnia, Cognitive Behavioral
Therapy for Insomnia (CBT-I), is a multi-component behavioral intervention. However, cognitive impairments
experienced by individuals with MCI may limit the rate of progress in CBT-I. The use of memory support
strategies can improve patient recall of therapeutic information, enhance treatment adherence, and improve
treatment outcomes. Cognitive Symptom Management and Rehabilitation Therapy (CogSMART) provides
compensatory strategies to improve learning, memory, attention, and executive functioning. CogSMART has
been shown to improve cognition, functional capacity, neurobehavioral symptoms, and quality of life in diverse
Veteran populations with cognitive impairment. Incorporating supportive CogSMART cognitive strategies into
CBT-I has the potential to improve treatment learning, adherence, and outcomes for this Veteran population.
Significance: This RR&D SPiRE research project will assist us in developing and evaluating Sleep-SMART
(Sleep Symptom Management and Rehabilitation Therapy), an innovative user-informed approach for
treatment of insomnia in Veterans with MCI. Sleep-SMART is intended to provide the core components of
CBT-I along with training in compensatory cognitive strategies from CogSMART to enhance intervention
adherence and learning. Provision of this supportive cognitive training will assist Veterans with cognitive
impairments in maintaining compliance with the CBT-I regimen, thereby leading to faster and more complete
treatment benefits. Aims: Our principle aims for the investigation include: 1) developing the Sleep-SMART
intervention and treatment manual; 2) assessing the feasibility and acceptability of Sleep-SMART in Veterans
with MCI and insomnia; and 3) exploring the effects of Sleep-SMART on rehabilitation outcomes, quality of life,
sleep, and cognitive functioning. Methodology: We propose to develop the Sleep-SMART intervention and
manual over the first 6 months of the project (Phase I) using a participatory research approach guided by the
Intervention Mapping Adapt framework. We will subsequently assess the feasibility and acceptability of Sleep-
SMART (Phase II) by enrolling 26 Veterans ages 60 and older to receive six 50-minute weekly sessions of
individual Sleep-SMART treatment via secure video-conferencing. Feasibility will be assessed through
recruitment metrics, level of Veteran participation in the treatment, clinician fidelity to the treatment protocol,
and evaluation of barriers to treatment implementation. Acceptability will be assessed primarily through
questionnaires and other measures assessing satisfaction, acceptability, appropriateness, and adherence to
the intervention. While efficacy is not our primary aim, we will collect some initial data for estimating effect
sizes to assist in future power calculations. Veterans will be asked to complete specific measures of disability,
independent living skills, quality of life, sleep, and cognitive functioning. Next Steps: Pilot data acquired from
this investigation will be used for application(s) to conduct randomized controlled trials investigating the
efficacy of Sleep-SMART in Veterans with MCI and insomnia compared to standard CBT-I or treatment as
usual. The results of this investigation will also be used to inform scale-up implementation and dissemination
efforts.

Public health relevance
Cognitive Behavioral Therapy for Insomnia (CBT-I) is the first-line treatment for chronic insomnia. However, cognitive impairments may limit progress in CBT-I for older Veterans with Mild Cognitive Impairment (MCI). This study will develop and pilot test Sleep-SMART (Sleep Symptom Management and Rehabilitation Therapy), an adapted CBT-I treatment that incorporates Cognitive Symptom Management and Rehabilitation Therapy (CogSMART) principles with a goal of improving sleep treatment and rehabilitation outcomes for Veterans with co-occurring MCI and insomnia. The innovation of this study centers on enhancing CBT-I by providing supportive cognitive strategies designed to improve treatment adherence, learning, and acceptability. We anticipate that by improving sleep we can concurrently improve daily functioning, increase quality of life, prevent or reduce late-life disability, and mitigate long-term cognitive decline in this Veteran population.